Heterochromatin dynamics during inheritance and adaptation

PROJECT ABSTRACT
Retaining pre-existing histone modifications that control gene expression is essential to maintain cellular
identity. Yet, cells often encounter unexpected changes to their environment that force them to rewire
transcription. My overall vision is to determine how the dynamic properties of the epigenome can be tuned to
ensure stable inheritance during development while enabling plasticity during adaptation. Histone H3 lysine 9
methylation (H3K9me) is essential to form transcriptionally silent heterochromatin domains, which play crucial
roles in maintaining genome stability and cellular identity. This process depends on a minimal set of core
factors that are conserved in organisms ranging from yeast to humans. Fission yeast (Schizosaccharomyces
pombe) is an outstanding model system to develop a molecular scale understanding of how heterochromatin is
established, maintained, and dynamically remodeled during stress. Despite the stable nature of
heterochromatin silencing, the interactions between heterochromatin proteins and H3K9me nucleosomes,
paradoxically, are highly dynamic. These observations highlight significant conceptual and methodological
gaps that we will address during the next five-year period: 1) How do cells integrate transient protein binding
events on the millisecond timescale to enforce stable epigenetic silencing across multiple generations? 2) How
do cells exploit transient interactions to form heterochromatin at new locations in the genome during
adaptation? In this proposal, we use a multi-disciplinary approach combining genetics and genomics,
biochemistry, and microfluidic tools to elucidate how cells reconcile the need for stability with plasticity in
establishing and maintaining heterochromatin. Uncovering these molecular architectures will enable us to
envision and design new classes of chromatin states that are robust, durable, and yet flexible to change in
response to external cues.

Public health relevance
PROJECT NARRATIVE Heterochromatin establishment is crucial for centromere and telomere function, silencing repetitive DNA sequences, transposons, and maintaining lineage-specific gene expression patterns. Abnormal heterochromatin spreading is associated with cancer and genetic diseases, such as repeat expansion disorders like Fragile X syndrome and Facioscapulohumeral muscular dystrophy. Our research program aims to build a mechanistic understanding of how cells memorize gene expression states to catalyze therapeutic intervention strategies premised on the tunable manipulation of heterochromatin in living cells.